Pilot Core

Project Summary
The goal of this Columbia Roybal Center for Fearless Behavior Change is to develop and test novel
interventions for improving medicationadherence and physical activity in distressed survivors of acute medical
events. Each year, millions of middle aged and older adults experience heart attacks, strokes, or diagnoses of
life-threatening illnesses such as cancer. For some, these events serve as a wake-up calls, or “teachable
moments,” and those patients acquire health behaviors that help to prevent recurrent events and slow disease
progression. However, many patients who experience these events as highly distressingavoid secondary risk-
reducing medications and physical activity. We have shown that such patients avoid medications because they
are reminders of disease risk, and exercise because physiological changes (e.g., heart rate) are distressing
reminders of the possibility of a recurrent event. As a result, while highly distressed patients seemingly have
motivation to adopt more healthful behaviors, most do not. We posit that existing behavior change
interventions have largely failed to improve health behaviors because they have not addressed fear/avoidance
behaviors that are pervasive after a life-threatening medical event. Accordingly, our Roybal Center will develop
interventions that target fear-based mechanisms.
We will initially focus on survivors of acute cardiovascular disease (CVD) events, of whom approximately 1 in 3
patients have elevated fear of recurrence, interoceptive bias, or psychophysiological reactivity to reminders of
their CVD events (e.g., intrusive thoughts, medications, follow-up visits). In Year 1, we will conduct stage I
intervention development research, to test and refine novel interventions to reduce fear of recurrence and
prevent interoceptive bias using exposure-based interventions. In later years, we will further develop the most
promising interventions, and solicit proposals for new approaches consistent with our Center’s theme. We will
direct interventions at the high risk period from hospitalization through the first month after discharge,
beginning at the inpatient bedside, anduse standard electronic behavior and mechanism assessment devices
across studies. We will prioritize early stage investigators for new pilots, and provide world-class research
infrastructure. We will initially focus on CVD, but we will include experts in other conditions in which fear
plays an important role (e.g., cancer and COPD) for later interventions.
As leaders of the Science of Behavior Change (SOBC) program, we are experts in applying the experimental
medicine approach to produce simple, efficient, and potent behavior change interventions that are likely to be
adopted by stakeholders. Accordingly, our Roybal Center holds tremendous promise for developing theory-
derived interventions that are likely to have a substantial impact on the health behaviors of the most vulnerable
patients who survive acute medical events.

Public health relevance
Project Narrative Most adults will experience an acute life-threatening medical event in their lifetime, and the distress that it will cause many of them will manifest as fear of recurrence, hypersensitivity to and threatening interpretations of physiological signals, and psychophysiological reactivity to reminders of risk. We have found that these fear- based mechanisms cause patients to avoid health behaviors that reduce risk for recurrent medical events, so our Columbia Roybal Center for Fearless Behavior Change will develop and test interventions to prevent or reduce those fear-based mechanisms and assess whether better behaviors result. Our established collectivist scientific culture, emergency department-based recruitment infrastructure, and standardized electronic assessment suite for behavior and mechanisms assessment will ensure that the pilot studies conducted in our Center are well-positioned to successfully yield impactful interventions.